SPOT-IT: Sepsis Prediction in Oncology Through Implementation Science and Technology

Project Abstract
Patients with cancer face unacceptable morbidity and mortality from sepsis, a life-threatening dysregulated
response to infection. Oncologic sepsis contributes to > 15% of cancer hospitalizations and 10% of cancer
deaths in the US, with far greater morbidity and mortality than noncancer sepsis. Timely evidence-based
sepsis care bundles improve outcomes, but are frequently initiated too late or not at all in cancer, suggesting
that earlier accurate recognition may improve care and outcomes. Current approaches to detecting and
treating oncologic sepsis suffer from interrelated limitations including poor accuracy of sepsis prediction tools in
patients with cancer as well as general and oncology-specific barriers to their effective implementation. This
Career Development Award will support Patrick G Lyons, MD, MS, in addressing this challenge while
completing his development into an independent physician-investigator with the training and experience
necessary to improve cancer care delivery in the hospital. The overall goal of Sepsis Prediction in Oncology
Through Implementation Science and Technology (SPOT-IT) is to use EHR data to develop an oncology-
specific sepsis prediction model using machine learning and to use human centered design methods to design
and evaluate the usability of a stakeholder-informed implementation strategy for this model. These themes fit
with the NCI’s goal of “rapid development, testing, and refinement of innovative approaches to implement...
evidence-based cancer control interventions” and the DCCPS’s priority areas in healthcare delivery research
and implementation science
and are reflected in the Aims: 1) develop an oncology-specific sepsis prediction
model using machine learning on EHR data; 2) design and refine implementation strategies to improve
oncologic sepsis management; and 3) conduct a pilot trial to determine the early implementation and process
outcomes of SPOT-IT. These Aims link to Dr. Lyons’s career development objectives: 1) develop core cancer
care delivery knowledge, (2) enrich his knowledge in sepsis epidemiology and outcomes, (3) advance his skills
in machine learning and informatics, (4) gain advanced skills in implementation science and human centered
design, and (5) enhance his scientific leadership skills. Dr. Lyons will achieve these goals via a 5-year career
development plan incorporating didactics, fieldwork and experiential research, and intensive mentoring by Terri
Hough, MD (an international leader in sepsis epidemiology and pragmatic implementation research), Brandon
Hayes-Lattin, MD (an oncologist specializing in stem-cell transplantation and clinical trials), and Matthew
Churpek, MD, PhD (a critical care physician and informaticist with expertise in machine learning using EHR
data). Dr. Lyons’s experienced multidisciplinary team of mentors and advisors, combined with the exceptional
research environment at Oregon Health & Science University, will provide the support and training necessary
to achieve his long-term goal of becoming a leading cancer care delivery scientist.

Public health relevance
Project Narrative Because hospitalized patients with cancer face unacceptable morbidity and mortality from sepsis (a life- threatening dysregulated response to infection), there is urgent need for interventions to identify oncologic sepsis early and enable timelier appropriate treatments. However, incumbent electronic health record-based sepsis prediction tools – linked to improved mortality in other populations – have failed to deliver on their promise in oncology because of design and implementation limitations. This project aims to advance the simultaneous and iterative development of a machine learning tool to predict oncologic sepsis alongside the user-centered design of implementation strategies to improve sepsis care and outcomes for hospitalized patients with cancer.